Chameleon Sample Preparation Device for Cryo-EM

PROJECT SUMMARY
Recent technological advances in cryogenic-electron microscopy (cryo-EM) have heralded a “resolution
revolution” that has made it possible for high-resolution structures to be determined for a variety of targets that
had eluded other structural techniques. Despite these advances, cryo-EM grid preparation remains a formidable
roadblock to successful structure determination in many cases. Indeed, despite improvements in electron optics,
camera technology, and image analysis, and a general drive towards automation, cryo-EM grid preparation
remains a laborious and unpredictable process that requires extensive manual user input for optimization. The
University of California, San Diego (UCSD) has established a world-class cryo-EM facility with state-of-the-art
electron microscopes and staff, yet numerous projects across campus remain stalled due to an inability to
prepare high-quality cryo-EM grids from purified specimens. To address this bottleneck in the cryo-EM workflow
at UCSD, we propose to purchase an SPT Labtech Chameleon sample vitrification instrument. This instrument
represents the first major innovation in cryo-EM grid preparation in over 30 years, with an entirely novel approach
to sample application that yields more reproducible cryo-EM grids, improves particle quality and distribution, and
generally increases the likelihood of high-resolution structure determination. The instrument will be centrally
housed and operated within the recently renovated UCSD Cryo-EM Facility and will be available to all trained
users at UCSD, surrounding institutions in the La Jolla “Mesa” area, and across California. For users at UCSD,
this instrument will catalyze progress in a broad range of NIH-funded, biomedically-important projects spanning
neurodegeneration, virology, membrane trafficking, DNA replication and repair, immunology, and protein
biogenesis and folding.

Public health relevance
PROJECT NARRATIVE Producing high-quality frozen grids with evenly-distributed, natively-folded macromolecular complexes in vitreous ice remains a major bottleneck in the process of structure determination by single-particle cryogenic- electron microscopy (cryo-EM). This proposal requests funds for a SPT Labtech Chameleon that will be used by 17 NIH-funded scientists across five departments at The University of California, San Diego (UCSD) and two surrounding institutions to prepare high-quality cryo-EM specimens for high-resolution structure determination. This next-generation cryo-EM sample preparation device eliminates many of the hurdles that have plagued cryo- EM sample preparation for the past 30 years, and will significantly boost a variety of cryo-EM projects spanning neurodegeneration, virology, membrane trafficking, DNA replication and repair, methods development, immunology, and protein folding and biogenesis.